Local Modulation of Inflammation to Heal Cranial-facial Bone Defects

DESCRIPTION (provided by applicant): Bone defects cause functional deficits as well as disfigurement that can severely harm the patients' physical and psychological health. Unlike bone fractures that are usually treated immediately after injury, most cranial-facial bone defects are treated after the initial pathological condition or traumatic injury has been resolved. Thus, methods to heal these defects must promote bone formation at a quiescent site while prohibiting growth of soft tissues into the defect site that stop bone formation. One difficult aspect of bone tissue engineering in the craniofacial and dental areas is complications from soft tissue ingrowth into the active site of new bone formation. Soft tissue ingrowth into a device essentially halts further bone formation. This host response creates a challenge for tissue engineering in that any solution must limit soft tissue interference without impairing bone formation or inducing so much new bone formation that the desired functional or aesthetic morphology of the new bone is not achieved. Our goal is to engineer a device that balances rapid bone formation with limited soft tissue interference that can augment or heal cranial-facial bone defects. Having shown that arachidonic acid metabolism can modulate inflammation related to bone formation, we propose to develop a device that separates cyclooxygenase inhibition (limits soft tissue growth) from 5-lipoxygenase inhibition (promotes osteoblast activity and bone formation). We will use a poly (anhydride-ester) of salicylic acid (PolyAspirin) to inhibit cyclooxygenase and a 5-lipoxygenase inhibitor within a calcium sulfate carrier and calcium phosphate scaffold to promote osteogenesis. The use of small molecule inhibitors as the active ingredients of this device will allow production of low-cost, long shelf-life devices for treating cranial-facial bone defects.

Public health relevance
PUBLIC HEALTH RELEVANCE: Bony defects of the skull and other cranial-facial bones are common traumatic and pathological injuries. Current methods to treat cranial-facial bone defects are associated with second-site morbidity from autograft harvest, use of potentially infectious allograft bone, poor long-term efficacy, technically challenging procedures, and high costs. Our goal is to develop a low-cost, easy to use and store, tissue engineering device to treat cranial-facial bone defects that accelerates healing by modulating the host inflammatory response. Bony defects of the skull and other cranial-facial bones are common traumatic and pathological injuries. Current methods to treat cranial-facial bone defects are associated with second-site morbidity from autograft harvest, use of potentially infectious allograft bone, poor long-term efficacy, technically challenging procedures, and high costs. Our goal is to develop a low-cost, easy to use and store, tissue engineering device to treat cranial-facial bone defects that accelerates healing by modulating the host inflammatory response. __SpecificAimsTextDelimiter__ SPECIFIC AIMS There is a clear clinical need for therapies to heal cranio-facial and periodontal bony defects. Often these treatments occur at a quiescent site, that is, a site that is in physiological homeostasis though an obvious bony defect exists. Treating these defects using a tissue engineering device that can restore functionality and appearance to the patient is an attractive strategy. However, any such device must be amenable to custom fabrication or the manufacture of large numbers of different sized components in order to meet individual patient needs. Further, such a device should be economical with no special storage requirements enabling its ready use by a large number of qualified practitioners. Current tissue engineering devices to heal cranio-facial and periodontal defects rely upon use of osteoconductive materials and osteopromotive (rhPDGF-BB) or osteoinductive (rhBMP-2) growth factors. While growth factors can have significant positive effects on bone regeneration, the proteinaceous nature of growth factors creates serious challenges in terms of growth factor delivery, compatibility of materials and methods, storage conditions, and economy of use. Our goal is to develop a tissue engineering device that can efficiently and quickly heal cranio-facial or periodontal bony defects by controlling the inflammatory reaction using small molecule compounds. Our group brings together diverse expertise in periodontal device development, biomaterials, polymeric drug delivery systems, osteogenesis, and regulation of inflammation to create new technologies for controlling osteogenesis. We will meld the anti-inflammatory and potential resolution of inflammation characteristics of cyclooxygenase inhibition with the pro-osteogenic effects of 5-lipoxygenase (5-LO) inhibition into a tissue engineering device that will separate these anti-inflammatory and pro-osteogenic activities in space and time. Based upon our strong preliminary data, this device will be useful for treating cranio-facial and periodontal bone defects. Specifically we intend to address the following hypothesis. Hypothesis: Bone formation can be promoted and controlled at orthotopic sites by spatially and temporally inhibiting components of the inflammatory pathway. To test this hypothesis, we will develop a PolyAspirin-5-Lipoxygenase Inhibitor Scaffold (PALIS) device through directed and subsequent iterative design testing that can be used to repair craniofacial and dental bone defects. This will be accomplished as outlined in the following Aims. Aim 1. Measure host osteogenic response to local 5-lipoxygenase inhibition at a cranial bone defect. a. Define optimal 5-lipoxygenase inhibitor dose using calcium sulfate as a carrier in an established hydroxyapatite-tricalcium phosphate scaffold. b. Determine efficacy of combining local 5-lipoxygenase inhibitor therapy with additional osteo-promotive or osteo-inductive growth factors. Aim 2. Measure host inflammatory and soft-tissue responses to PolyAspirin-coated and 5- lipoxygenase inhibitor containing scaffolds. a. Measure degradation profile of PolyAspirin coated scaffolds in vitro. b. Measure host inflammatory response to implantation of porous scaffolds coated with PolyAspirin. c. Measure host arachidonic acid metabolism at scaffold sites in response to PolyAspirin, 5-LO inhibition, and both. Aim 3. Test the efficacy of the optimized PALIS device in a pre-clinical, cranio-facial defect model.